Johns Hopkins Rheumatic Diseases Resource-based Core Center (Johns Hopkins RDRCC)

Overview
PROJECT SUMMARY
The abiding philosophy of the Johns Hopkins Division of Rheumatology is that the critical pathway to
understanding human autoimmune rheumatic diseases is through the study of large numbers of well-defined
patients, followed over time, with the collection of rich phenotypic data, mapping disease trajectory, and where
possible, acquiring and storing relevant biological materials from blood and target tissue. This repository
of data and samples can then be used to separate heterogeneous diagnostic groups into more homogeneous
subgroups, using tools that span the entire spectrum of investigation. This P30 provides the framework for
organizational (oversight, management), operational (recruitment, sampling, processing), measurement, and
analytical (statistical, computational, and integrative) expertise to enable effective clinical and translational
research. The RDRCC competitive renewal comprises an Administrative Core (Core A) led by Drs. Antony
Rosen and Clifton Bingham, and includes 3 scientific Cores: (i) Core B is the Precision Medicine Data
Integration Core, co-led by Dr. Bingham and Dr. Ami Shah; (ii) Core C is the Sample Processing and
Immunoassay Research (SPIRE) Core, co-led by Dr. Livia Casciola-Rosen and Dr. Erika Darrah; and Core D
is the Data Science Core, led by Dr. Scott Zeger. The Center is structured as a matrix, designed to foster
collaborative and synergistic discovery by maximizing access of the diverse research community to data and
samples from humans with rheumatic diseases. Core A will promote efficient, interdisciplinary research
throughout the research community and Cores, and manage the enrichment program. Core B will work with
our Centers of Excellence to bring their research operations onto the Johns Hopkins Precision Medicine
Analytical Platform (PMAP) enhancing clinical and research integration through the Epic electronic medical
record system. Core C will coordinate patient sample processing, storage and distribution, and provide multiple
immunological assays for discovery and validation of biomarkers and disease pathways. Core D will provide
highly innovative tools to enable analysis of complex longitudinal data in rheumatic disease patients,
particularly with the design and application of hierarchical models to identify disease subsets.

Public health relevance
Overview PROJECT NARRATIVE This Rheumatic Diseases Resource-based Core Center (RDRCC) provides systems and infrastructure to facilitate efficient and significant research on humans with rheumatic diseases. The synergies that arise from coupling the diverse and well-resourced research community to a rich collection of prospectively-collected data and samples from patients with rheumatic diseases through provision of Core service and expertise provides unprecedented opportunities to enhance and accelerate discovery into the causes, mechanisms, diagnosis, therapy and prevention in these diseases.